Regulation of mesoderm fate patterning through multiscale dynamics

PROJECT SUMMARY
Human development intricately relies on precise fate determination during gastrulation, a pivotal stage
where a uniform epithelium undergoes dynamic rearrangement to form the diverse tissues of the body plan.
Classical embryology has identified pathways and gene expression patterns guiding predictable tissue
formation, yet emerging hypotheses reveal a deeper complexity in cellular behavior and fate determination.
When a cell dynamically alters its physiology to migrate in response to nearby signals, its microenvironment
undergoes continuous changes as it moves. How does the cell interpret these dynamic shifts to regulate its
downstream functions effectively?
This proposal delves into the dynamics of early mammalian development, focusing on mesoderm cell
behavior during gastrulation and its implications for tissue formation and cell fate. I aim to challenge the
conventional notion of embryonic development as a linear series of phases by dissecting the interplay between
cell movement and the changing milieu, highlighting the dynamic and non-linear nature of tissue formation.
Exploiting an in vitro gastruloid model, I will explain the mechanisms underlying mesoderm migration, offering a
unique opportunity to dissect migration dynamics and their impact on tissue organization. My preliminary data
suggests that mesoderm cells exhibit high motility and contribute significantly to downstream tissue
organization, highlighting the potential of altering migration kinetics to influence mesoderm architecture.
Through a combination of genetic perturbations, functional analysis, and computer vision, this proposal
aims to establish a novel approach to understand the regulatory pathways governing mesoderm migration and
its role in tissue architecture. How does the physical environment dynamically influence mesoderm fate? To
address this question, my project is twofold: firstly, unraveling the mechanisms regulating mesoderm cell
migration during fate patterning; and secondly, understanding how migration dynamics shape tissue form and
influences cell fate decisions. Overall, this study aims to uncover fundamental insights into the complexity of
mesoderm cell behavior during embryonic development. These findings contribute to our broader goal of
understanding and eventually controlling cell behavior.

Public health relevance
PROJECT NARRATIVE Early human development hinges on the dynamic interplay of cellular behaviors shaped by the surrounding milieu. This project investigates how cell migration molds these environments, fostering tissue diversity and complexity crucial for both regeneration and disease contexts. These insights will provide valuable pathways for understanding and manipulating cell behavior in tissue development, wound healing, and disease progression.